TOXICOLOGY CONSULTING FOR REPRODUCTIVE SCIENCE

This contract is to provide support for consulting services on reproductive toxicology for the Contraception Research Branch of the Eunice Kennedy Shriver National Institute of Child Health and Human Development.
The Contractor shall have extensive experience with the rigorous design and conduct of reproductive pharmacology and related studies. The contractor should have specialized expertise in reproductive pharmacology and toxicology.